Cell Circuits and Immunology Core

CELL CIRCUITS AND IMMUNOLOGY CORE: PROJECT SUMMARY
The Cell Circuits and Immunology Core will be co-directed by Andrew Luster and Shiv Pillai. Core services
are comprised of routine immunology tools, specialized immunology services, and education and training
designed to facilitate studies of the human immune system. The Core maintains a commitment to the
development and implementation of methods to facilitate immune monitoring and define laboratory correlates of
clinical observations. Routine immunological tools offered by the Core include flow cytometry, high-speed cell
sorting, Luminex bead assays, and multiplex cytokine and chemokine arrays. The Core strives to provide access
to cutting edge tools to drive progress in digestive disease and mucosal immunology research. To this end, a
number of specialized services are offered to Center members, including generation of MHC I and II tetramers
and novel pathway-based computational approaches combined with CRISPR screens. As a result of
development and implementation of groundbreaking methods for single cell genomic profiling (e.g., single
nucleus RNA-seq and Perturb-Seq) as well as the recent establishment of a single cell facility, investigators have
access to the tools necessary for profiling immune cells across tissues at high resolution. Recently developed
high-definition spatial transcriptomics and multiplexed RNA FISH techniques allow investigators to analyze the
spatial distribution of transcriptomic data. As part of its commitment to education and training, the Core provides
consultations and instruction on experimental design of immunological assays, method implementation, and
bioinformatics analysis.
The CCI Core strives to enhance cohesion between basic immunology, translational and clinical aspects of IBD
towards the goal of understanding the basic mechanisms underlying inflammation and autoimmunity. The
specific aims of the Cell Circuits and Immunology Core are to (1) provide CSIBD members with access to
immunological resources that would otherwise be cost-prohibitive to individual researchers; (2) offer CSIBD
investigators access to cutting-edge immunological techniques that are at the forefront of immunology research;
and (3) promote the development of junior investigators and foster collaborations by providing a connection point
between investigators of varying research approaches.